IT AND TELECOM- OTHER IT AND TELECOMMUNICATIONS

The scope for this contract is to provide development, enhancement, maintenance, and integration support for the Cancer Therapy Evaluation Program ? Enterprise System (CTEP-ESYS) including work that involves other systems that are supported or utilized through the NCI, which may result in integration with the CTEP-ESYS.